PHASE I STUDY OF TNP-470 IN THE TREATMENT OF AIDS-ASSOCIATED KAPOSI'S SARCOMA

This study explores the use of TNP-470, an inhibitor of blood vessel formation on Kaposi's sarcoma, based on the rationale that KS development is dependent in part on blood vessel proliferation.